Genomics and Bioinformatics Group web site development and maintenance

We are successfully maintaining and expanding the Discover web-based tools, with emphasis on the CellMinerCDB's. Our CellMiner "NCI-60 Analysis Tools" section remains a significant resource for pharmacogenomic integration, research, and discovery. It is currently the host for multiple tools, including i) Cell line signature, ii) Cross-correlation, iii) Pattern comparison, and iv) Drug vs gene variant/isoforms variant, all of which are designed to reduce the time required by the scientist to integrate molecular and pharmacological data. We continue to upgrade both the software and databases in this section. We currently provide the most inclusive set of molecular and largest compound activity data among any of the large-scale cellular databases. The CellMiner data and tools are creating major opportunities for progress in rational drug discovery, application, and individualization of therapy for cancer patients. As molecular alterations of many types can contribute to the outcome of therapy, the Genomic and Pharmacolgy Facility (GPF) manages and integrates molecular and pharmacological data in such a way that enhances understanding and facilitates the generation of testable hypotheses. The GPF thus both provides access to high throughput data, and provides software resources that facilitate the mining, understanding, and exploitation of that data. As the DTP drug database contains ~24,000 drugs as well as unexplored compounds, it remains an unmatched resource both for recognition of potential novel drugs and improving understanding of pre-existing ones. The NCI-60 is by far the most comprehensively profiled panel of mammalian cells anywhere. CellMinerCDB (cross database) is a web-applications have expanded the CellMiner concept and approach, integrating the multiple additional cell line sets, additional data types as well as providing on-the-fly results. Billions of data comparisons are available for the user, to be guided by their areas of interest and expertise. We continue to update the information as it becomes available. CellMinerCDB: Small Cell Lung Cancer (SCLC) is analogous in structure and functionality to CellMinerCDB, except with the restriction for only SCLC cell lines. This is designed as a resource for our branches interest in SCLC as well as other SCLC researchers and is described more extensively in PMID 33086069. CellMinerCDB: Sarcoma in like fashion to the above SCLC site is designed to be restricted to only sarcoma cell lines. It is designed as a resource for our branches interest in sarcoma as well as other sarcoma researchers and is described more extensively in PMID 38868205. CellMinerCDB: National Center for Advancing Translational Science (NCATS) site is designed to be a portal to the extensive NCATS drug data for the public. NCATS has contributed drug activities for many none cancer drugs, allowing the same types of molecular and phenotypic insights as previously made available for the cancer drugs and compounds. This web-application is described more extensively in PMID 37140427. CIMminer produces clustered image maps. This web-application is described more extensively in PMID 8994024. MIMminer is a repository of the electronically navigable Kohn Molecular Interaction Maps. This web-application is described more extensively in PMID 16267266 and 21586134.